Systematic evaluation of toxicity and therapeutic efficacy in CD46 directed radioligand therapy

PROJECT SUMMARY AND ABSTRACT
The primary goal of this proposal is to optimize our promising CD46 directed radioimmunotherapy method and
to systematically test the therapeutic efficacy and toxicity utilizing state of the art metastatic cancer models.
Readouts of therapeutic efficacy and toxicity will include histologic, metabolomic, and microscale dosimetry
analysis. Our preliminary data and prior publications demonstrate great promise for CD46 directed
radioimmunotherapy. The central hypothesis is our proposal is that optimized CD46 directed
radioimmunotherapy will allow for effective prostate cancer treatment with relative sparing of normal tissue
toxicity. This hypothesis will be tested in relevant orthotopic and disseminated metastatic models, using readouts
including histology, metabolomic, and microscale dosimetry analysis.
Guided by PAR-22-139, we have assembled a multidisciplinary multi-PI team including nuclear medicine
physicians, specialists in cancer metabolism and animal model development, physicists, radiochemists, experts
in antibody drug development, and pathologists. In aim 1, we develop novel bifunctional chelators for antibody
labeling to maximize tumoral delivery of the therapeutic 225Ac. In aim 2, we systematically test the optimized
radioimmunotherapy agents in clinically relevant metastatic prostate cancer models. In aim 3, we develop a
multi-part therapeutic and toxicologic readout incorporating metabolomic, histologic, and microscale dosimetry
analysis. Overall, the methods developed in this proposal promise to advance CD46 directed
radioimmunotherapy, and will have significant impact upon the field of radiopharmaceutical therapy in general.

Public health relevance
PROJECT NARRATIVE: This proposal describes the development and optimization of CD46 targeted radioimmunotherapy, and the systematic testing and evaluation of the method in preclinical models of prostate cancer. Novel chemical methodology is utilized to optimize the delivery of therapeutic radiation to tumor while minimizing healthy tissue delivery. A major focus of the proposal is the utilization of novel, clinically relevant metastatic PCa models, and the evaluation of the therapeutic efficacy and toxicity using a combination of histologic, microscale dosimetry, and metabolomic analysis.